Atlantic Emerging Technologies & Industrial Hygiene Training Center

Abstract Atlantic Emerging Technologies & Industrial Hygiene Training Center The project will establish the Atlantic Emerging Technologies & Industrial Hygiene Training Center (Atlantic Training Center) as a multi-lingual training center with extensive online programing. Hunter College School of Urban Public Health (Hunter) and the City University of New York School of Public Health will act as lead institution in collaboration with the Rutgers School of Public Health (Rutgers) Office of Public Health Practice and the School of Environmental Affairs at Universidad Metropolitana (SEA-UMET). The collaboration between Hunter, Rutgers and SEA-UMET to create the Atlantic Emerging Technologies & Industrial Hygiene Training Center is important because it allows expansion and development of Superfund research and education in Region 2, areas with extremely high density of Superfund and Brownfields sites. The Atlantic Training Center will immediately provide graduate level academic training in emerging technologies at Hunter's two masters programs: the ABET accredited graduate program offering a MS in Industrial Hygiene and the CEPH accredited graduate program offering a MPH in Environmental and Occupational Health Sciences. The Atlantic Training Center will also develop industrial hygiene coursework in the MS in Environmental Management at SEA-UMET in San Juan, Puerto Rico with the goal of seeking accreditation for a new concentration in Environmental and Occupational Health Sciences from the Puerto Rico Council of Education. In short, the project will fund ten graduate students per year at Hunter's campus in New York City and ten graduate students per year at SEA-UMET's campus in San Juan -- for a total of 100 students over the five years of the project. Regarding the overall program participants, 62% of the trained graduate students will be women, and the majority (60% at Hunter and 99% at SEA-UMET) identify as individuals from racial and ethnic groups shown by the NSF as underrepresented in health sciences; many also come from low- income, disadvantaged backgrounds. The faculty for the program is also diverse regarding gender and ethnicity: the PI for the lead institution is a woman and the PI for SEA-UMET is a Hispanic female. Finally, the Atlantic Training Center will offer ten (10) online, multi-lingual continuing education courses for industrial hygienists, environmental consultants and those working in the field as live 1.5 hour broadcasts from New York, New Jersey and Puerto Rico for 100 participants per course per year (for a total of 5000 participants). The continuing education program will produce 50 high quality videos on emerging technology that will be posted on the Internet to be viewed for free at any time. 1

Public health relevance
Narrative This project will establish the Atlantic Emerging Technologies & Industrial Hygiene Training Center to increase occupational health and safety management practices and skills in the areas of emerging technologies in Region 2, an area with an extremely dense concentration of Superfund and Brownfields sites. The project will provide graduate level academic training in emerging technologies from a diverse faculty to fund twenty (20) graduate students per year: ten in New York City and ten in San Juan -- for a total of 100 students over five years, most of whom will be women and who identify as individuals from racial and ethnic groups shown by the NSF as underrepresented in health sciences. The project will also offer ten (10) free online, multi-lingual continuing education courses for industrial hygienists, environmental consultants and those working in the field as live 1.5 hour broadcasts for 100 participants per course per year (for a total of 5000 participants) that will be recorded and posted on the Internet as fifty (50) high quality training videos that can be viewed for free at any time. 1